Mechanisms of Alveolar Homeostasis, Injury, Regeneration, and Fibrosis

PROJECT SUMMARY
Acute and chronic parenchymal lung diseases, such as the acute respiratory distress syndrome (ARDS) and
idiopathic pulmonary fibrosis (IPF), are associated with significant morbidity and mortality. Therapies are limited,
largely due to our incomplete understanding of disease pathogenesis. These diseases arise from injury to the
alveolar epithelium with ineffectual regeneration. In accordance with the NIH mission to “seek fundamental
knowledge about the nature…of living systems and apply that knowledge to enhance health”, we aim to identify
mechanisms by which alveolar homeostasis is maintained, disrupted during injury, and restored during
physiologic regeneration and how these processes go awry in the pathogenesis of ARDS and IPF.
The normal alveolus consists of alveolar type 2 epithelial cells (AEC2s) and AEC1s, which form a tight barrier,
with quiescent fibroblasts and alveolar macrophages. The molecular mechanisms of cell-cell crosstalk that
maintain alveolar quiescence during homeostasis are poorly understood. During lung injury, AECs die. Severe
acute injury results in barrier permeability, leading to ARDS; clinical recovery requires epithelial regeneration. In
IPF, repetitive epithelial injury with impaired regeneration begets fibrosis. However, the mechanisms underlying
physiologic regeneration and how it is impaired in the pathogenesis of IPF are incompletely understood.
AEC2s are the primary progenitor responsible for physiologic alveolar regeneration. AEC2s proliferate, then
differentiate into AEC1s. We and others have identified mechanisms of AEC2 proliferation. Moreover, we were
the first to identify a novel transitional cell state transiently assumed by regenerating AEC2s before differentiating
into AEC1s. We also found that transitional cells persist in pulmonary fibrosis, suggesting that persistence of
transitional cells may be the critical regenerative defect driving fibrosis. However, the mechanisms that induce
AEC2s to assume the transitional state and transitional cells to differentiate into AEC1s during physiologic
regeneration and by which transitional cells persist and promote fibrosis in IPF are unknown.
Here, we will explore the mechanisms of alveolar cell-cell crosstalk that maintain homeostasis and promote
physiologic regeneration and how these mechanisms go awry in ARDS and fibrosis. We will use lineage tracing
combined with AEC2-specific inducible gene knockout in mouse models of homeostasis, injury, physiologic
regeneration, and fibrosis. Cultured human and murine AECs will be used to dissect mechanism. The proposed
work will fill fundamental gaps in our understanding of alveolar homeostasis and physiologic and
pathologic regeneration and overcome critical barriers to the development of novel therapies for ARDS
and IPF. The funding will also support the pursuit of new lines of investigation and the dedication of appropriate
time and energy into collaborations, professional service, and mentorship.

Public health relevance
PROJECT NARRATIVE Acute and chronic lung diseases such as the acute respiratory distress syndrome (ARDS) and idiopathic pulmonary fibrosis (IPF) result from injury to the alveolar epithelium with ineffectual regeneration. Unfortunately, effective therapies are limited, in large part because our understanding of disease pathogenesis is incomplete. By dissecting mechanisms underlying alveolar homeostasis and normal regeneration, and how these go awry in disease pathogenesis, the proposed work will fill fundamental gaps in our knowledge and overcome critical barriers to the development of novel therapies for ARDS and IPF.